Evolutionary Systems Biology of Host-Parasite Interactions

ABSTRACT
There are fundamental gaps in our understanding of how genome-wide functional genetic
variation in host-parasite interactions is shaped by natural selection, including for humans.
Parasitic helminths (including nematodes) present important selective agents on host traits and
underlying genetic variation. Geographic clines in infection pressure, as helminths are ectothermic
(temperature-sensitive), may drive genomic and phenotypic variation across host populations.
This, in turn, may influence parasite adaptation. However, mechanistically linking agents of
selection with targeted traits and their underlying genetic architecture in hosts and parasites
remains formidably challenging. Only when resolved, will we understand how selection drives
evolution of host resistance and immune system suppression and evasion by parasites. The
investigator’s long-term goal is to gain mechanistic understanding, including of the genetic
architecture of key host and parasite traits. The laboratory’s five-year objective is to identify these
key traits, investigate their genetic basis, and functionally verify genetic variants regulating them.
The core hypothesis is that coevolving hosts and parasites exert selection, pressuring one
another to adapt through genetic and phenotypic changes. The rationale is that populations of
plants and their nematode parasites, as genetically tractable model systems, show spatial and
temporal variation in infection rates, which has a genetic basis, allowing comprehensive
mechanistic studies of this issue. Working off the investigator’s prior research and robust
preliminary data, this hypothesis will be tested through: 1) identifying genome-wide changes
underlying geographic variation in plant resistance to nematode parasitism, and 2) determining
genetic mechanisms and constraints underlying host resistance-breaking in nematodes. An
evolutionary systems biology approach will identify genes, genetic networks and genomic variants
underlying adaptive traits. This will be combined with parasite resurrection ecology and
experimental evolution to study real-time evolutionary change. The investigator showed
previously that such approaches will successfully identify key traits and genes involved in species
interactions. Molecular genetic experiments will link candidate adaptive genetic variants with
functional traits and fitness. This innovative research program will form a key step toward
integrative comprehension of how host-parasite interactions are shaped by selection on
phenotypic and genome-wide genetic variation. It holds promise for uncovering general principles
relating to how host-parasite interactions evolve, helping predict sustainability of human
interventions in shaping such interactions towards better outcomes for humans.

Public health relevance
NARRATIVE The research proposed has significant relevance to public health because there are not many study systems to investigate the mechanisms underlying evolutionary genetic and phenotypic changes in host-parasite interactions. Parasitism by helminths (worms) is hypothesized to have driven population genetic changes in human, animal, and plant hosts, contributing to auto-immune pathologies and placing burdens on growth and development, but data obtained using a combination of evolutionary, genome-wide, and functional genetic approaches from genetically tractable host-parasite study systems is necessary to address this question. Thus, the research proposed pertains to NIGMS's research mission of understanding the principles, mechanisms, and processes that underlie living organisms, and NIH’s mission area of developing fundamental knowledge that will help to (1) sustainably reduce the burdens of parasitism and autoimmune pathologies and (2) advance our understanding of how selection shapes genetic and phenotypic variation in hosts and parasites over time.